Central Microscopy

The major goal of the Central Microscopy Research Facility (CMRF) is to provide high-quality microscopy
services to cancer research projects, ensuring that Holden Comprehensive Cancer Center (HCCC)
investigators have access to the latest instrumentation and techniques to enhance their work. The facility
provides access to approximately $10 million in equipment including light, confocal, and electron microscopy of
a variety of different types. It also supports cancer researcher access to specialized staining and embedding of
samples, negative staining, metallic coating, autoradiography, cryo-fixation, enzyme and immuno-
cytochemistry, morphometry, stereology, X-ray microanalysis and microdissection. The facility is accessible
seven days/week, 24 hours/day to trained investigators and staff. The CMRF is directed by Randy Nessler,
who has 29 years of experience in this facility, and brings this tremendous experience and expertise to serve
the research needs of HCCC investigators. The six full-time staff members have a combined total of +90 years
of microscopy research experience, with many years devoted to cancer research.

Public health relevance
PROJECT NARRATIVE Not applicable